Regulation of stem-like CD8+ T cells and their role in immunotherapy

PROJECT SUMMARY
Immune checkpoint receptors (e.g. CTLA-4, PD-1, Tim-3) are expressed on dysfunctional or “exhausted” CD8+
tumor-infiltrating lymphocytes (TILs) that exhibit defective effector functions (cytotoxicity and pro-inflammatory
cytokine production) and are thus poor mediators of tumor clearance. In the last decade, immune checkpoint
blockade (ICB) has achieved durable responses in many cancers, including melanoma, lung, and renal cancer.
Despite this success, current estimates indicate that only 12% of all cancer patients respond to ICB. These
observations underscore the remaining unmet clinical need in cancer treatment and the need to understand what
constitutes effective response to ICB in order to improve response rates.
Through examination of the population and single-cell RNA profiles of CD8+ TILs upon ICB, we have identified
stem-like CD8+ TILs that are integral for the response to ICB. These cells are tumor antigen-specific, exhibit
polyfunctional effector capacity, and increase in proportion upon various ICBs across different cancer types.
Although the transcription factor TCF-1 plays an important role in the maintenance and effector function of these
cells, we have found that TCF-1 expression in CD8+ T cells is not requisite for positive response to ICB in all
tumor contexts. These observations underscore the relevance of stem-like CD8+ TILs for effective response to
ICB and the need to better understand how TCF-1 and additional factors regulate their biology.
Stem cells reside in niches where crosstalk between stem cells and other cells in the niche regulates not only
their maintenance and function but also the function of niche cells. We have found that tumor-associated dendritic
cells (DCs) are altered when TCF-1 is absent in mature CD8+ T cells. We thus hypothesize that 1) stem-like
CD8+ TILs reside within niches in the tumor micro-environment (TME) where they interact with and modulate
antigen-presenting cells; 2) this intercellular communication circuit within the niche may be required for effective
priming of anti-tumor T cell responses; and 3) modulation of stem-like CD8+ TILs may positively or negatively
influence this communication circuit, thus affecting the efficacy of ICB.
Our overarching goal is to understand the cell-autonomous regulation of stem-like CD8+ TILs, their
crosstalk with other cells in the TME, and how together they govern the activation of proficient anti-
tumor CD8+ T cell responses and ICB efficacy. Accordingly, we propose the following aims: 1) Determine the
role of TCF-1 in the generation of proficient anti-tumor T cell responses; 2) Test the role of novel candidate
regulators of stem- and effector-like CD8+ TILs, and 3) Characterize the crosstalk between stem-like CD8+ TILs
and the TME.

Public health relevance
PROJECT NARRATIVE Cancer is a significant cause of morbidity and mortality worldwide. Immune-based therapies are showing great success in treating cancer; however, a large fraction of patients still fails to respond to these therapies. The proposed studies will advance our knowledge of the immune cells that drive response to therapy and how their modification relates to successful outcome.